Liquid cartilage for arthroscopy

PROJECT SUMMARY
This multi-PI proposal is a collaboration among tissue engineers and an orthopaedic surgeon to develop a liquid
cartilage filler, called chondrogel, that would be efficacious in repairing gouge and focal defects of the knee using
an arthroscopy approach. Chondrogel is formed using extensively passaged, allogeneic rib chondrocytes that
have retained their ability to form mechanically robust neocartilage that is phenotypically akin to articular cartilage
(e.g., production of collagen II and lubricin, absence of collagen I and X). Preliminary data show that chondrogel
fills gouge defects in explant culture and also in vivo after 16wks in the minipig knee. We have also developed
arthroscopic techniques for the minipig. In this proposal, we will show that, in addition to gouge defects,
chondrogel will be effective in healing focal defects as well when administered arthroscopically. This will be
achieved in two aims. In Aim 1, we will examine chondrogel 1) to show that, in addition to 20x1mm gouge defects,
chondrogel is capable of filling focal defects 5mm in dia. in explant culture (Aim 1, Phase I), and 2) to find the
maximum arthroscopic intraarticular pressure where chondrogel is still retained in gouge and focal defects (Aim
1, Phase II). In Aim 2, we will determine if chondrogel heals gouge and focal articular cartilage defects in the
minipig using arthroscopy. Because chondrogel has been designed based on surgeon surveys and because it
is based on rigorous science demonstrating its ability to form cartilage, successful completion of this proposal
would allow the use of arthroscopy to treat cartilage defects.

Public health relevance
PROJECT NARRATIVE The overall objective of this proposal is to advance “chondrogel,” an allogeneic, cell-based filler that is essentially liquid cartilage, for gouge and focal cartilage defects as administered through an arthroscopic approach. Each year, an estimated 750,000 Americans undergo arthroscopy, and, although gouge and focal defects are frequently observed, no efficacious arthroscopic treatment exists. Chondrogel would address this pressing need especially given that, if left untreated, cartilage lesions typically worsen over time.